Optimizing Implementation in Cancer Control: OPTICC - Implementation Lab Core

IMPLEMENTATION LABORATORY CORE SUMMARY
The Implementation Laboratory Core will establish and coordinate a network of diverse clinical and community
sites that can conduct the OPTICC Center’s implementation science (IS) studies, implement cancer control
evidence-based interventions (EBIs), and shape the Center’s research agenda. The Implementation Lab has
recruited five research-ready Lab Partners that include diverse clinical sites across our 5-state Washington,
Wyoming, Alaska, Montana, and Idaho (WWAMI) region. The Lab Partners are all established networks
experienced with collaborative multi-site research and/or quality improvement efforts. The Lab includes primary
care and cancer care clinics, outpatient and inpatient settings, and rural and urban environments that provide
care to traditionally underserved populations, permitting implementation studies that address health disparities.
The Implementation Lab has four specific aims. Aim 1 is to establish administrative procedures to ensure
effective, efficient coordination of the Implementation Lab and promote productive, mutually beneficial
collaborations between Lab Partners and the OPTICC Center. Aim 2 is to support collaboration between
Implementation Lab Partners and OPTICC Study Leads in multiple, concurrent innovative implementation
studies, measures and methods studies, and pilot studies that address three stages of optimizing EBI
implementation in cancer control. Aim 3 is to develop infrastructure and processes to support large-scale
implementation studies that involve data sharing across Lab Partners and harmonized procedures for human
subjects, data safety and monitoring. Aim 4 is to monitor Implementation Lab Partners’ ongoing cancer control
EBI implementation initiatives; track progress, successes and challenges of Center-supported EBI
implementation efforts; and identify emerging implementation priorities to inform the Center’s research agenda.
Our Lab Partners’ on-the-ground implementation priorities, initiatives and challenges will drive OPTICC
investigators’ implementation study aims and methods. The Implementation Lab’s expected outcomes include
improved implementation of cancer control EBIs in clinical and community settings; a “learning laboratory”
through which Lab Partners engage in peer learning and gain access to practice tools, guidance, and findings
from the Center’s studies, and OPTICC investigators learn about real-world implementation initiatives and
challenges that drive IS; and a research infrastructure that can participate in the larger, follow-on, multi-site,
multi-level studies that will emanate from OPTICC and other Advanced and Developing Centers.